Center for Molecular, Cellular, and Translational Immunological Research

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To enhance the pace of research by ensuring that knockout and transgenic mice become available much more rapidly for use in pre-clinical studies.